Einstein Lupus Cohort Core

Core Leader: Chaim Putterman. A central element of the U19 grant is the collection and characterization of patients with systemic lupus erythematosus (SLE), related autoimmune conditions, and normal controls. This requires protocol-driven identification of subjects, standardized recording of medical history, epidemiological information, family history, and the collection and storage of high-quality biospecimens. Underpinning all of this is a secure, accessible database assuring data integrity and interoperability. The specific aims of the Clinical Resource Core (CRC) are: 1. Recruitment of subjects with SLE and related conditions, disease controls, and healthy controls; 2. Collection of demographic, clinical, and epidemiological data with storage in a secure, confidential database; 3. Collection and storage of serum, urine, DNA, and RNA for distribution to researchers in this program, from affected and unaffected family members. 4. Immortalization of B cells to provide a resource of cells for isolation of stress-related RNPs and testing of immunomodulatory effects

Public health relevance
Several aims in collaborative projects rely on the use of material derived from human subjects. In order to facilitate these projects, we will use a CRC facility for the recruitment subjects, centralized collection of information and specimens for use by multiple investigators, and computational support. Archiving of DNA form affected and unaffected family members will facilitate future genomic sequencing studies.